Dissecting the circuit-level mechanisms of ultrasound neuromodulation

ABSTRACT
Transcranial low-intensity focused ultrasound (LIFU) is an emerging modality for noninvasive and targeted
modulation of cortical and deep targets in the human brain. LIFU has enormous potential to realize a
transformative treatment for myriad neurological and psychiatric disorders, but significant challenges exist for
the clinical translation of LIFU neuromodulation protocols due to the unknown underlying neurophysiological
mechanisms and the relatively large parameter space that remains poorly understood. Dissecting the
mechanistic underpinnings of LIFU neuromodulation with systematic and carefully controlled experimental
approaches is a critical step to facilitate the effective development of therapeutic protocols. Recent studies have
established that LIFU elicits differential responses in diverse neuronal cell types depending on the pulsing
parameters
. However, dynamic circuit-level effects resulting from synaptic interactions between cell types have
remained largely undisclosed. In this project, we will develop a systematic approach based on cutting-edge
technologies to generate new fundamental knowledge on the underlying mechanisms of LIFU neuromodulation
in specific cell types, focusing on circuit and network-level effects. In our analysis of the temporal dynamic
responses, we will directly assess whether LIFU can enhance gamma-frequency (30-100 Hz) neural oscillations,
which play a key role in information processing and cognition and are implicated in the pathophysiology of many
neuropsychiatric disorders, including autism, schizophrenia, and neurodegenerative disorders. In all the
proposed experiments, we will implement carefully designed control conditions to disentangle direct
neuromodulatory outcomes from potential nonspecific auditory effects. In Aim 1, we will use cell-type specific
fluorescent calcium indicators to map the LIFU neuromodulation parameter space in excitatory neurons and in
parvalbumin (PV) and somatostatin (SST)-positive inhibitory interneurons. These cell types are particularly
interesting due to their specialized role in the generation of gamma oscillations. In Aim 2, we will record cell-
type-specific transmembrane voltage dynamics from cortical excitatory and inhibitory neurons to shed light on
the circuit-level responses to LIFU neuromodulation. In Aim 3, we will use functional ultrasound imaging to map
whole-brain network-level responses. Taken together, our Aims will yield new fundamental insights on the
underlying mechanisms of LIFU neuromodulation. Excitingly, our Aims will lay the groundwork for a clinically
translatable approach to systematically modulate neural oscillations in deep brain regions.

Public health relevance
PROJECT NARRATIVE This proposal aims to dissect the underlying mechanisms of low-intensity focused ultrasound neuromodulation in cortical microcircuits, focusing on circuit and network-level dynamic effects. We will establish carefully controlled experimental approaches to quantify direct neuromodulatory responses resulting from interactions between neuronal populations. This research could facilitate the effective development of translational ultrasound neuromodulation protocols for treatment of neuropsychiatric disorders such as autism, schizophrenia, and neurodegenerative disorders.